Host immature myeloid cells in tumor suppressor or promoter roles of TGFbeta

This is a new lab starting in January of 2009. We are in a process to produce and breed mouse colonies in which TGFbeta R2 receptor is specifically deleted in tumor cells or host immature myeloid cells. During this short time we have established all technical procedures needed for this project. A new postdoc is hired with 100% effort devoted to dissecting the underlying mechanisms of inflammation in TGFbeta signaling in breast cancer progression. We have obtained preliminary data supporting our hypothesis.